Administrative Core

The purpose of the Administrative Core is to support the translational research objecfives of the SPORE by providing: (1) management and coordinafion of the daily activifies of the SPORE program, (2) administrative direcfion and structure for the invesfigators, (3) support for scienfific activities of the SPORE investigators, and (4) scientific programmatic oversight of projects and cores in collaboration with internal and external advisory committees. The Administrative Core is responsible for the following: submission of reports and non-competing renewal applications to the NIH, facilitating communication among SPORE investigators, organization of conferences and seminars, management of the clinical soft tissue sarcoma database, coordinafion of the sarcoma soft tissue resource, and sponsored travel of SPORE investigators to scientific meetings. In addition, the core will schedule and coordinate the SPORE investigators' attendance at annual SPORE meetings and annual reviews by the Internal and External Scientific Advisory Committees. This core will assist David Spriggs, MD, in administering the Career Development Program, including promofion of the fellowship program and recruitment of minority participants. Finally, the Administrative Core, in conjunction with MSKCC's Office of Sponsored Projects, will administer the funds of the SPORE. This work will be performed under the direcfion of the Principal Investigator, Samuel Singer, MD.